National/Regional Resource Core: Accelerating Health Equity And Eliminating Diabetes Disparities in Community Health Centers (AHEAD-CHC)

PROJECT SUMMARY - National/Regional Resource Core
The overall goal of the national core is to catalyze equity-focused diabetes translation research in community
health centers (CHC), the primary ambulatory system of care for vulnerable populations across the U.S. The
proposed core, entitled Accelerating Health Equity And Eliminating Diabetes Disparities in Community Health
Centers (AHEAD-CHC), engages three of the largest and most capable CHC network organizations nationwide:
AllianceChicago (Alliance), Health Choice Network (HCN), and MidWest Clinicians' Network (MWCN).
Collectively, these organizations support a total of 246 CHC sites across 29 U.S. states serving ~7.5 million
patients. AHEAD-CHC will also partner with Clinical Directors Network (CDN) for dissemination activities
reaching a national audience of relevant stakeholders in all 50 states. AHEAD-CHC leverages the following
existing assets and critical infrastructure to accomplish the aims of this national Core successfully. In Aim 1,
Alliance and HCN will expand an existing National Diabetes Data Repository that currently includes over 1 million
CHC patients, and make this resource available to a national audience of diabetes translation researchers and
CHC clinicians for equity-focused analyses. In Aim 2, Alliance, HCN, and MWCN will offer a range of consultative
services to support collaborations pairing diabetes investigators with CHCs, and help catalyze successful
practice-based research by these groups. Specifically, AHEAD-CHC partners will leverage existing infrastructure
to offer consultations, participate in meetings, and provide analytic support to accelerate new diabetes translation
research conducted in their CHC networks. In Aim 3, AHEAD-CHC offers a national dissemination arm led by
CDN, which will leverage its existing audience of over 50,000 researchers, CHC staff, and other stakeholders
for a webinar series featuring diabetes research supported by the Core. CDN will then archive the webinars on
the AHEAD-CHC website, along with associated research products (e.g. peer-reviewed publications,
intervention protocols, and white papers), so that these materials can be accessed on demand by an unlimited
audience. With extensive collective experience conducting high-impact diabetes research in CHCs and then
translating findings into improved diabetes care and outcomes, members of the AHEAD-CHC leadership team
are national authorities in this area, who are uniquely positioned to succeed in the proposed work. AHEAD-CHC
is highly responsive to RFA-DK-20-002 by: 1) focusing on health equity among the vulnerable, high-risk
populations served by CHCs; 2) offering resources and services that catalyze work across the research
continuum from partnership building to translation of research products into practice and policy; 3) enhancing
efficiency, productivity, and effectiveness by centralizing these diverse assets and making them available from
a single access point; and 4) demonstrating established reach beyond the Chicago Center for Diabetes
Translation Research into all 50 U.S. states.